HPTN SDMC: HPTN 096 Getting to Zero among Highest HIV Incidence (HHI) Men who have Sex with Men (MSM) in the American South: Testing an Integrated Strategy

Abstract (30 lines)
The Southern United States continues to experience the highest HIV incidence in the country, with
men who have sex with men (MSM) disproportionately affected. HPTN 096 is a multi-component,
community-based implementation-efficacy trial designed to reduce HIV incidence among the highest
HIV incidence (HHI) MSM in three urban American South communities. The primary study outcomes
are increasing the number of HHI MSM accessing prevention and treatment services, increasing
uptake and use of pre-exposure prophylaxis (PrEP) among those living without HIV, and increasing
retention in care, and thus viral suppression among those living with HIV. Intervention process
outcomes will assess implementation fidelity, reach, acceptability, and provider training effects.
HPTN 096 is a hybrid implementation-efficacy trial that uses a single-arm interrupted time series (ITS)
design to test whether a status-neutral integrated strategy improves access to and uptake of HIV
prevention and treatment services for HHI MSM. The four components of the ITS are: Health access
coalitions, Social media, Peer support, and Promoting Human Autonomy Supportive Environments
(PHASE). ITS measures a change in slope for the primary outcomes pre- and post-intervention using
four one-year lookbacks of EMR data. The integrated strategy will be delivered in three communities
(Dallas, TX; Montgomery, AL; Ft Lauderdale/ Miami, FL) in the American South. Additionally, a subset
of HHI MSM at PHASE healthcare facility (HCF) sites, as well as PHASE HCF staff, community
coalition members, peer supporters, and both HHI MSM and other individuals who engage with the
intervention’s social media content will be assessed for secondary outcomes and primary intervention
process outcomes.
By integrating multiple intervention strategies at the community and healthcare facility levels, HPTN
096 aims to generate evidence for scalable approaches that reduce HIV incidence in high-burden
populations in the American South. The use of electric health records from participating health care
clinics to assess the HPTN 096 study outcomes is an innovation for the HPTN.

Public health relevance
Project Narrative (3 sentences) HPTN 096, “Getting to Zero among Highest HIV Incidence (HHI) Men who have Sex with Men (MSM) in the American South: Testing an Integrated Strategy,” will evaluate a status-neutral integrated strategy to improve access to and use of HIV prevention and treatment services across high-need communities. The goal is to establish a strategy to reduce HIV incidence among MSM in the southern United States (US). The primary study outcomes are increasing the number of HHI MSM accessing prevention and treatment services, increasing uptake and use of pre-exposure prophylaxis (PrEP) among those living without HIV, and increasing retention in care, and thus viral suppression among those living with HIV. This funding request will support the four intervention components, including health access coalitions, social media engagement, and healthcare facility engagement in three southern communities: Dallas, TX; Montgomery, AL; and Ft. Lauderdale/Miami, FL.